HDL as a therapeutic target for sepsis

Sepsis is a major health issues for public and for veterans. A recent study conducted in
118 VA hospitals showed that 4.1% of patients undergoing surgery developed
postoperative sepsis. The mortality rate of sepsis is high, exceeding 30%, due to a lack
of efficient therapy. A great barrier for sepsis therapy is that sepsis is a multi-factor
disease, involving endotoxin from bacteria, dysregulated response in immune effector
cells, all of which lead to cell damage and endothelial dysfunction, resulting in organ
injuries and septic death, which may explain why extensive efforts (more than 100
clinical trials) to block one or another component of the inflammatory or coagulation
pathways have had little impact on patient survival. Here, we propose that targeting an
endogenous factor with multi-protective effects against sepsis may present a novel
approach for sepsis therapy and high density lipoprotein (HDL) is such a target. HDL is
a major component of circulating blood with multi-protective properties in vascular
endothelial cells and immune effector cells. However, the levels of HDL decrease by 40-
70% in septic patients, which is associated with a poor prognosis. Using mice deficient
in HDL, we recently reported that mice lacking HDL are susceptible to cecal ligation and
puncture (CLP)-induced septic death, and increase HDL levels protects CLP-induced
septic death. These clinical and animal studies indicate that a decrease in HDL levels is
a risk factor for sepsis and raising circulating HDL levels may provide an efficient
therapy for sepsis. Reconstituted or synthetic HDL (sHDL) is a new tool for promoting
the biological activity of HDL. In the preliminary study, we generated a new type of
sHDL (YGZL3) and showed that the YGZL3 treatment significantly increases HDL levels
and protects mice from CLP- and bacterial-induced septic death, indicating that sHDL
(YGZL3) is a potential effective therapy for sepsis. Based on our preliminary data and
existing knowledge of HDL biology, we hypothesize that sHDL therapy protects sepsis
by restoring both HDL level and its multi-protective functions. The objectives of this
grant are to understand the mechanism(s) underlying sHDL (YGZL3) protection against
sepsis, to optimize the treatment regimen and to assess pharmacokinetics and toxicity
of sHDL (YGZL3). Completion of this study will provide a body of mechanistic and
preclinical data for a novel sHDL-based therapy for sepsis and position it for future
Investigational New Drug (IND) studies and rapid clinical translation, which will improve
the health of public and veterans.

Public health relevance
Sepsis is a major health issues for public and for veterans. The mortality rate of sepsis is high, exceeding 30%, due to a lack of efficient therapy. A great barrier for sepsis therapy is that sepsis is a multi-factor disease, which may explain why extensive efforts (more than 100 clinical trials) to block a single component in inflammatory or coagulation pathways have had little impact on patient survival. Here, we propose a new approach for sepsis therapy - targeting multiple factors in sepsis with a new type of synthetic high density lipoprotein (sHDL, YDZL3). Our proposal is well-supported by clinical findings, the existing knowledge of HDL and our preliminary studies. Completion of this study will provide a body of mechanistic and preclinical data for a novel sHDL-based therapy for sepsis and position it for future Investigational New Drug (IND) studies and rapid clinical translation, which will improve the health of public and veterans.